Leadership, Planning and Evaluation

Leadership, Planning, and Evaluation: Summary/Abstract
The HDFCCC is driven by its tight network of leaders, planning and tracking activities, and regular evaluation
internal and external groups. These leadership, planning, and evaluation resources allow the HDFCCC to be
immediately responsive to member needs and address issues as they arise, as well as engage in
comprehensive strategic planning. The HDFCCC has been strategic and intentional in designing leadership
groups, advisory groups, and roles, and in aligning them with the Cancer Research in 2030 strategic plan.
HDFCCC Administration is integrated within each group, with members serving as active participants and
experts, as well as serving as support staff for conducting meetings, tracking action items, and operationalizing
ideas. The HDFCCC accomplishes its leadership, planning, and evaluation activities across the Center by (1)
establishing a leadership structure that supports and is responsive to member needs and the HDFCCC
mission; (2) conducting strategic planning and implementing appropriate outputs; and (3) defining and tracking
metrics of success and convening appropriate advisory groups.